Knockout Models of PDZ Domain Proteins

Use continuation pages as needed to provide the required information in the format shown below. Start with Program Director(s)/Principal Investigator(s). List all other senior/l<ey personnel in alphabetical order, last name first. Name eRA Commons User Name Organization Roie on